Multidisciplinary Training in Translational Gastrointestinal and Liver Research

Project Summary/Abstract
This application from Columbia University requests a third competitive renewal of a postdoctoral training program
in digestive and liver diseases. The program, last reviewed in October 2018, is designed to provide research
training opportunities for physician-scientist trainees in Gastroenterology-based fellowship programs, to prepare
them into becoming independent basic, clinical and translational investigators. The T32 program, which has
been in existence for fourteen years, takes advantage of many of the existing strengths of Columbia University,
including a number of Centers and Departments and the broad framework of research at the university. The
program has a long record of success, with >80% of the trainees that completed the program currently in
academic positions at top universities and medical centers in the U.S., most with external funding. A major
strength of the program is the highly collaborative and well-funded faculty as well as the many recent faculty
recruits and the new, NIH-funded Digestive and Liver Diseases Research Center at Columbia. In addition, the
training program builds on the highly academically oriented residency and fellowship programs in both adult and
pediatric gastroenterology. Our trainees are selected from a very large pool of outstanding applicants to these
clinical training programs. Special efforts have been undertaken to enhance our recruitment of women and
minorities, aided by recent structural changes to our program; and the mentoring of women and minority trainees
has thus become a major focus of the program. Dr. Timothy C. Wang is the PI and Director of this training
program, ably assisted by Associate Director Dr. Howard Worman; and both have actively mentored young basic
and clinical scientists for many years with superb track records in training. They are assisted by other members
of the Executive Committee and supported by both Internal and External Advisory Committees. Trainees have
a wide choice of mentors in basic GI, basic liver, or clinical/epidemiological research, and in addition to exciting
research projects, they also complete a rigorous program of didactic instruction that includes cross training and
multidisciplinary education. Many of our trainees will pursue training in Patient Oriented Research (POR) and
obtain a Masters (MSc) degree. Key milestones for our trainees include publications, especially first-authored
papers, and applications for career-development awards such as K awards and later R01 awards. The training
program and associated departments have a well-established seminar series and journal clubs/workshops,
career development and mentoring program, and an efficient feedback and evaluation system. In summary, this
is a highly successful research training program of physician-scientists in digestive and liver diseases.

Public health relevance
Project Narrative While digestive diseases continue to affect over 60 million people, causing nearly a quarter million deaths per year at a cost of over $135 billion, there remains a shortage of physician-scientists in the field who can identify new strategies for treatment and prevention. Our T32 program at Columbia trains physicians in the design and execution of high-quality, clinically relevant research in digestive and liver diseases, and we seek to continue our highly successful program in preparing future physician-scientists in the GI field.